Molecular mechanism of the visual disorders caused by G90D and G90V rhodopsin mutations

PROJECT SUMMARY/ABSTRACT
Vision begins in photoreceptor cells with light activation of the visual pigment, rhodopsin, which triggers a
transduction cascade to produce the cellular electrical response. A wide range of blinding disorders have been
associated with mutations in rhodopsin. From these, mutations of Glycine 90 to Aspartate (G90D) and to Valine
(G90V) have been reported to cause congenital stationary night blindness (CSNB) and retinitis pigmentosa (RP),
respectively. Structural and biochemical in vitro studies have shown that the G90D/G90V mutations cause
rhodopsin destabilization that could interfere with normal light detection. However, despite decades of research,
the mechanisms by which these mutations cause vision loss remain unclear and effective treatments for people
with these mutations are not available. To address these questions, we have created G90D and G90V rhodopsin
knockin mice. We will perform comprehensive analysis of these mice to determine the phenotype of their rod
photoreceptors. These experiments will include morphological analysis and in vivo eletroretinography and single-
cell suction electrode recordings to determine the physiological properties of the mutant rods, combined with
microspectrophotometric and biochemical analysis to determine the molecular properties of the mutant mouse
rhodopsins (Aim 1). We will perform experiments to determine the molecular mechanisms by which the G90D
and G90V rhodopsins cause blindness by evaluating the stability of their covalent bonds between opsin and
chromophore, the binding and release of chromophore, and the equilibrium between chromophore-free and
chromophore-bound mutant opsins (Aim 2). Finally, we will also test the efficiency of genome editing for rescuing
the function of rods with the G90D or G90V rhodopsin mutations (Aim 3). Together, these experiments will
establish the unique disease mechanisms of two distinct human visual disorders caused by mutations in the
same residue of rhodopsin and will develop therapeutic approaches for reversing their effects that could
eventually be used in human clinical studies. Analyzing our G90D and G90V mutant mice side by side will also
help understand why these two similar mutations produce distinct clinical phenotypes.

Public health relevance
PROJECT NARRATIVE The experiments outlined here will identify the mechanisms by which two similar rhodopsin mutations, G90D and G90V, cause visual impairment using G90D and G90V knockin mice that we have generated. This proposal will seek to provide full structural and functional photoreceptor analysis of these animals, determine the molecular mechanism by which these rhodopsin mutations cause night blindness and retinal degeneration, and develop therapeutic approaches for reversing their effects.